Mechanical Forces and the Regulation of Airway Progenitor Cells

PROJECT SUMMARY
The branched architecture of the airways of the lungs permit the transfer of approximately six liters of air per
minute between the external surroundings and the alveoli. The airway epithelial tree accomplishes gas
exchange, mucus production, and pathogen clearance and blocks the entry of water, particulates, and
microbes. To accomplish these diverse biological functions, the airway epithelium is comprised of several
distinct cell types that differentiate from common progenitors during embryonic development, the first of which
is the pulmonary neuroendocrine cell. Disrupting the differentiation of the specialized epithelial cell types
negatively affects airway morphogenesis, and abnormally high numbers of pulmonary neuroendocrine cells are
found in several congenital and acquired diseases of the lung. As it differentiates, the epithelium secretes ions
and water across its apical surface, causing fluid to fill the lumen of the airways with a transmural pressure
high enough to inflate the lungs. Defects that cause a decrease in transmural pressure are associated with
both underdeveloped lungs and an increase in pulmonary neuroendocrine cells, but the specific role of
pressure and the molecular signaling downstream of this mechanical cue are unknown. By combining time-
lapse confocal imaging with an innovative microfluidic culture system, we found that transmural pressure
controls the rate of lung development and the expression of markers of neuroendocrine cells. Using next-
generation sequencing analysis, we found that low transmural pressure decreases the expression of targets of
Notch, the master regulator of pulmonary neuroendocrine differentiation, and YAP, a known mechanosensor.
Here, we hypothesize that transmural pressure coordinates the growth and differentiation of the different cell
types within the epithelium by signaling through Notch and YAP. We will combine microfluidic devices with
engineered mice, high-resolution time-lapse spinning disk confocal microscopy, and next-generation
sequencing analysis to define the relative roles of pressure, Notch, and YAP in the regulation of pulmonary
neuroendocrine progenitor fate decisions. In Specific Aim 1, we will use microfluidic chest cavities, engineered
mice, time-lapse imaging, and single cell RNA-sequencing to define physically how transmural pressure
regulates the pulmonary neuroendocrine population in the developing lung. In Specific Aim 2, we will use
microfluidic chest cavities, reporter mice, and chromatin immunoprecipitation approaches to define whether
and how transmural pressure regulates Notch signaling in the embryonic airway epithelium. In Specific Aim 3,
we will determine whether pressure signals through YAP to affect pulmonary neuroendocrine differentiation
and the Notch pathway. This work will define how mechanical signals from the microenvironment are
transmitted to the first progenitor fate decision in the developing airway epithelium. We expect that our results
will reveal novel insights into mechanical control of progenitor differentiation during tissue development and
suggest new therapeutic targets for defects in lung development.

Public health relevance
RELEVANCE Development of organs, including the lungs, is a physical process that requires coordinated growth and differentiation of multiple progenitor populations into the correct ratio of mature cell types to ensure function immediately after birth. Defects in the fluid pressure within the developing lungs can cause a reduction in lung development and alter the ratio of cell types within the airways, leading to catastrophic results. Here, we combine innovative microfluidic approaches with genetically engineered mice, quantitative imaging, and next- generation sequencing to define how pressure coordinates progenitor cell differentiation in the developing airways.